Hannah's Diversity Supplement grant

Project Summary/Abstract
Elucidating how our brain integrates information to elicit appropriate behavioral responses requires mechanistic
insights into how our sensory systems are wired to integrate diverse sensory modalities and transform them into
the neural codes of motor action. Studies of spinal cord circuits are well-suited to exploring these questions: the
direct link between sensory input and motor output (i.e., muscle contraction) affords an exquisite experimental
tractability that has been leveraged since Sherrington’s pioneering work on the proprioceptive reflex pathway.
Indeed, great progress has been made since then in understanding how proprioceptors (i.e., muscle sensory
neurons) shape motor activity. Touch receptors in skin encoding sensory modalities like vibration, indentation,
and slip, are also critical for adapting the way we walk in response to changes in our environment. However, the
spinal cord integration of touch pathways to sculpt motor activity remains profoundly poorly understood. To
address key conceptual and technical challenges in this field, we have built an extensive mouse genetic toolbox
to visualize, quantify and manipulate touch-specific spinal cord circuits. In addition, we merge these powerful
genetic tools with motor assays involving high-speed cameras, computer vision, and machine learning to quantify
somatosensory behavior with unprecedented sensitivity. Combining these technologies, we identified a novel
touch-specific premotor network important for sensorimotor function. Our overall hypothesis is that this network
represents a critical node for integrating touch and proprioceptive information to influence specific patterns of
muscle groups that facilitate both corrective movements during locomotion and motor ‘switching’ during
naturalistic behaviors. We interrogate this novel network to address fundamental questions whose answers will
enable an understanding of how touch pathways converge to shape movement. In Aims 1 and 2 we combine
genetic approaches, high-resolution synaptic analysis, slice electrophysiology and in-vivo muscle recordings to
test the hypothesis that this network integrates multimodal sensory information to influence specific muscle
responses to sensory input. Aim 3 combines joint and muscle activity recordings to test the hypothesis that this
network shapes cutaneous responses to facilitate corrective movements during locomotion. We extend these
behavioral studies by implementing computer vision and machine learning to parse out naturalistic behaviors
into sub-second movements to test the hypothesis that touch-specific premotor networks sculpt how micro-
movements are pieced together into complex motor behaviors
. By understanding the final path for movement
organization (i.e., the spinal cord) our research will lead to new therapies aimed at improving the quality of life of
people suffering from a variety of neurological disorders. Thus, this research lays the critical foundation for novel
ways of thinking about modulating spinal circuits for improving motor function.

Public health relevance
Project Narrative Our movements are sculpted by sensory information – yet though much progress has been made in understanding how proprioceptors (muscle sensory neurons) affect motor function, much less is known about how touch receptors (skin sensory neurons) influence motor pathways. To generate a complete picture of how sensory information affects motor actions, this project incorporates a multidisciplinary approach to provide a functional roadmap of how touch receptors of the skin interact with spinal cord motor centers to shape movement. By understanding the final path for movement organization (i.e., the spinal cord) our research lays the critical foundation for novel ways to modulate spinal circuits for improving motor function affected by disease or injury.